Uncovering the mesenchyme-specific roles of planar cell polarity in lung development

PROJECT SUMMARY
Breathing after birth requires a large alveolar epithelial surface and a thin mesenchymal barrier to promote
adequate gas exchange. In the fetus, this gas-exchange surface begins to form during the saccular stage of
lung development, when the distal ends of the epithelium expand into primary saccules at the same time as the
surrounding mesenchyme thins. Sacculation is arrested or delayed in premature infants, thus resulting in
significant decreases in lung function that persist into adulthood. Understanding the signals that promote
mesenchymal thinning would therefore permit strategies to treat sacculation delays. In the embryo, signaling
by noncanonical Wnts through the core planar cell polarity (PCP) pathway coordinates cellular rearrangements
that lead to convergence and extension of epithelial tissues. Our preliminary and published data show that the
PCP component, Vangl, is required in the lung mesenchyme but not the epithelium for sacculation.
Additionally, our data show that several core PCP pathway components, including Celsr, are absent from the
lung mesenchyme, suggesting that Vangl functions through a novel, mesenchyme-specific pathway to promote
mesenchymal thinning. Furthermore, we find that expression of the noncanonical Wnt5a in the mesenchyme is
required for sacculation. Here, we propose to take advantage of our innovative live-imaging platforms, tissue-
specific knockout mice, and endogenously tagged PCP-reporter mice to uncover the molecular, cellular, and
tissue-level mechanisms that connect Vangl to mesenchymal thinning during sacculation. We will combine
these approaches with atomic force microscopy, real-time fluorescence-based force sensors, super-resolution
imaging, unbiased proteomics, and single-cell transcriptomic analyses. In Specific Aim 1, we will determine
whether Vangl regulates the active or passive mechanical properties of the sacculating mesenchyme by
defining the effects of Vangl expression on cell motility and mechanical stiffness, respectively. In Specific Aim
2, we will test the hypothesis that Vangl promotes mesenchymal thinning by polarizing mesenchymal cells, and
identify the molecular components of the mesenchyme-specific PCP pathway. In Specific Aim 3, we will define
whether Vangl is activated by Wnt5a to promote mesenchymal thinning and extracellular matrix remodeling
during sacculation. This work will, for the first time, uncover the physical properties and molecular signaling
within the mesenchyme that promote late-stage lung development, and unveil the molecular players and
cellular consequences of a novel, mesenchyme-specific Vangl pathway. Our findings will have broad
implications for both lung developmental biology, in particular, and PCP signaling, in general.

Public health relevance
RELEVANCE During the second half of gestation, the lung prepares itself for breathing after birth by dramatically expanding its distal epithelial surface and thinning its mesenchyme. This process, known as sacculation, is interrupted by premature birth, which results in impairments in lung function that persist into adulthood. Here we combine innovative live-imaging approaches with transgenic mice, bioengineering, proteomics, and transcriptomics to measure the physical changes and identify the molecular signals that are essential for mesenchymal thinning during sacculation.